Neuronal nicotine acetylcholine receptors and the response to alcohol

DESCRIPTION (provided by applicant): Binge drinking is associated with significant short- and long-term health problems including impaired judgment, mood swings, and heart disease. Heavy alcohol users who frequently binge drink exhibit increased stimulant and rewarding responses to alcohol. Thus, understanding the molecular bases of alcohol reward and binge drinking should lead to identification of novel molecular targets for therapeutics designed to decrease alcohol consumption. Like nicotine and other drugs of abuse, alcohol activates dopaminergic (DAergic) neurons in the ventral tegmental area (VTA), which ultimately yields an increase in dopamine (DA) concentrations in the nucleus accumbens (NAc), a phenomenon widely associated with the rewarding or reinforcing properties of the drug. Previously, utilizing a combination of neuronal nicotinic acetylcholine receptor (nAChR) mouse models, pharmacology, behavioral assays, and electrophysiology, we determined that nAChRs containing the alpha4 subunit (denoted alpha4* nAChRs), previously found to be paramount in initiating nicotine dependence, are also involved in the rewarding properties of ethanol and binge drinking. Building upon previous studies, we will test the hypothesis that alpha4* nAChRs specifically in the ventral tegmental area (VTA) contribute to alcohol reward, consumption, and alcohol-mediated activation of VTA dopaminergic (DAergic) neurons. This hypothesis will be tested by re-expressing alpha4 nAChR subunits specifically in the VTA of alpha4 knock- out (KO) mice via viral-mediated gene delivery and measuring alcohol reward, binge drinking, and alcohol-mediated activation of VTA DAergic neurons compared to control KO mice. In addition, alpha4 subunits that are hypersensitive to agonist will be expressed selectively in distinct neuronal subpopulations within the VTA to determine how nAChR expression within VTA micro-circuitry affects alcohol reward and acute consumption. In aim 2, we will use molecular and biophysical approaches to test the hypothesis that ethanol-mediated activation of DAergic VTA neurons also involves nAChRs that contain the alpha6 subunit. Finally, aim 3 will determine how alpha6* nAChRs are involved in alcohol reward and consumption using a combination of mouse genetics and pharmacology. It is anticipated that the results from these experiments will yield valuable insight into the molecular underpinnings of alcohol reward and binge drinking, as well as identify potential targets for alcohol cessation therapeutics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alcohol abuse is the third largest cause of preventable mortality in the world. The goal of the proposed project is to understand how the known molecular targets of nicotine, nicotinic acetylcholine receptors, contribute to the rewarding effects of alcohol and binge drinking. The insights gained from this project should help identify novel molecular targets for therapeutics designed to reduce alcohol consumption.